The Impact of School Meal Delivery on Behavioral Disorders among Children in Health Disparity Populations

PROJECT SUMMARY
Policies to facilitate participation in school nutrition programs could reduce diagnosis rate disparities in
behavioral disorders, namely attention-deficit hyperactivity disorder (ADHD), oppositional defiant disorder
(ODD), and conduct disorder (CD). Food insecurity predisposes children to these conditions and aggravates
their symptoms. It impairs child development, contributes to inattention, and is associated with externalizing
behaviors. Preliminary data show that two school meal delivery options could make a difference. One is the
Community Eligibility Provision (CEP), which enables schools to provide free meals to all enrolled children,
regardless of household socio-economic status. The other is making school breakfast available after classes
begin (breakfast after the bell). There is growing evidence that these meal-delivery options reduce disciplinary
incidents at school, but no studies have incorporated information on diagnosis or utilization of services for
behavioral disorders. Our central hypothesis is that better access to school meals reduces the burden of
behavioral disorders among children in underserved communities who face an elevated prevalence of food
insecurity. There is evidence that exclusionary discipline (i.e., suspension or expulsion) contributes to an
escalation of behavioral issues, which may predispose the child to an ODD or CD diagnoses and/or
interactions with the juvenile justice system. Universal free meals and breakfast after the bell increase
participation in school meals and are feasible meal delivery options for many schools but remain underutilized.
Using a novel longitudinal all-payer claims database linked to educational achievement and disciplinary
outcomes, three specific aims are proposed:
1. Describe variation in medical diagnoses for ADHD, ODD, and CD across schools by race, ethnicity,
gender, age, rurality, and neighborhood characteristics.
2. Quantify the effect of school meal delivery policies and medical diagnoses on disciplinary outcomes and
academic achievement by race/ethnicity, rurality, and socioeconomic status.
3. Determine the effect of universal meals and breakfast after the bell, alone and in combination, on the
likelihood of diagnosed childhood behavioral disorders and subsequent service utilization overall and by
race, ethnicity, and rurality.
The study will draw from the population of Arkansas public schoolchildren. Arkansas ranks second in the
nation for the percentage of children diagnosed with ADHD, third in the percentage of children taking ADHD
medications, and second in the incidence of childhood food insecurity. Understanding whether policies to make
meals more accessible prevent the medical diagnosis of behavioral disorders that can escalate into disciplinary
events at school will have significant implications for improving health-related quality of life, human capital
development, and fewer encounters with the juvenile and adult criminal justice systems.

Public health relevance
PROJECT NARRATIVE Many children in underserved communities face food insecurity, which can adversely impact behavioral disorders. The study will use medical claims data linked to educational outcomes for Arkansas public schoolchildren to test whether school meal delivery options that make it easier to participate in child nutrition programs lead to improvements in discipline and academic performance at school. The study will also determine whether school meal delivery policies can reduce the diagnosis of behavioral disorders and associated healthcare utilization.